Abberior 3D-STED microscope for super-resolution imaging

PROJECT SUMMARY
We are requesting funds to purchase an Abberior Instruments FACILITY line 3D STED microscope to be
maintained in the Brandeis University Confocal Imaging Core Facility. This microscope will serve a primary user
group of 10 NIH funded investigators, and two junior faculty who will be applying for NIH funding, and we
welcome additional users from the biomedical sciences at Brandeis and the region. Our groups pursue a wide
variety of projects relevant to human health including aging, cancer biology, neurodegeneration, epilepsy,
learning and memory, and the origins of multicellular organisms. A common feature of these diverse studies is
a deep reliance on optical microscopy and an overarching interest in understanding how molecular-scale
structures (tens of nanometers in size) control cell and tissue-scale biological processes. A major barrier to our
progress in these areas is the lack of an imaging system at our institution that can resolve these tiny structures
of interest. Among the many strategies to overcome this resolution barrier (such as STORM, SOFI, and
expansion microscopy), a STED microscope is the ideal solution for our research community: It is fundamentally
a confocal microscope, and our user base has exceptionally broad and deep expertise in all aspects of confocal
microscopy including sample preparation, imaging, and rigorous quantitative image analysis. A STED
microscope would represent a five-fold improvement in resolution over our current capabilities and would open
up avenues of biology that are completely invisible to us now. Data collected on the instrument will help answer
many open questions: How do novel therapeutic nanoparticles target subcellular organelles to fight cancer? How
do signal sending and receiving structures at neuronal synapses assemble together to control learning and
memory or prevent epilepsy? How do molecules important to aging and neurodegeneration localize and function
at these synapses? Because of the small size of each of these structures, these are questions we cannot answer
with our current technology. Beyond the increase in resolution this system provides, it is equipped with features
that facilitate deep volumetric imaging and live imaging, which will allow us to perform experiments in vivo in
living tissues. Together, the Abberior STED system would profoundly improve our ability to discover how
nanoscale molecular and cellular structures control cell and tissue biology that is relevant to human health and
disease.

Public health relevance
PROJECT NARRATIVE The purchase of the Abberior FACILITY 3D STED would provide Brandeis University with its only true super- resolution (<50 nm) microscope, and dramatically advance the research aims of 10 NIH funded laboratories. The instrument will provide new insights into questions relevant to aging, cancer progression and drug development, learning and memory, neurological disorders such as PTSD and epilepsy, and neurodegenerative diseases including Alzheimer’s Disease.